Development of a Foot-Ankle Prosthesis to Improve Physical Therapy Outcomes

Reduced balance and balance confidence are common impairments among individuals with lower-limb
amputations. It is therefore important to develop and evaluate therapeutic interventions designed to improve
balance and balance confidence in this population. Conventional approaches to balance training currently
involve weight-shifting and stepping exercises that challenge single-limb stance and balance recovery. During
this time, new prosthesis users typically wear a flexible prosthetic foot-ankle mechanism designed for walking.
Although individuals with lower-limb amputations eventually adapt to the sudden balance requirements of their
new prosthesis, their confidence is likely influenced by a persistent threat of falling.
The long-term goal of this work is to compare a conventional approach of balance training with a modified
program in which the balance requirements of the prosthesis user are gradually increased. To vary the balance
requirements of the prosthesis user, a novel foot-ankle device will be developed at the Minneapolis VA Health
Care System (MVAHCS), which will allow therapists to gradually adjust the stability of the foot-ankle system as
patients learn to safely transfer weight over their prosthesis. This new device will enable physical therapists to
maximize stability at the beginning of physical therapy, thereby allowing patients to weight shift with a highly
stable system. As the patient's confidence increases, therapists will be able to gradually decrease the stability
of the device.
The primary goals of our development work will be to develop a prosthetic foot-ankle system that is durable
and that allows for easy adjustments (i.e., a system that requires little extra training or tools to accomplish).
Consideration will also be given to a method of tracking these adjustments so that therapists can document the
patient's progress during the course of physical therapy. Following each design iteration, we will mechanically
test the foot-ankle system for static proof, ultimate strength, and cyclic fatigue according to the ISO 10328
standard for lower-limb prosthetic components. We will then perform human subject testing to assess the
standing and walking performance of the device and obtain feedback to guide design modifications. Using
three-dimensional motion analysis and a clinical balance assessment system, we will collect kinematic, kinetic,
and postural stability data on a group of experienced prosthesis users (n=8) while they stand and walk with the
proposed foot-ankle system. The goal of this testing will be to ensure biomimetic function of the ankle and
verify expected kinematic changes with regard to its range-of-motion settings. We will also conduct human
subject testing on a group of new amputees (n=4) undergoing physical therapy at the MVAHCS, which will
provide an opportunity for the prosthetists and physical therapists involved in the study to gain experience with
the device. In parallel with our development efforts, we will develop a physical therapy protocol that leverages
the unique features of the foot-ankle system. The goal of this effort will be to provide an integrated solution to
balance training for Veterans with lower-limb amputations. Finally, we will implement an appropriately scoped
quality management system to document design criteria, reduce overall development costs, and increase the
likelihood of technology transfer. Ultimately, we believe that the foot-ankle system developed in this project will
lead to new approaches of physical therapy for individuals with lower-limb amputations, improving mobility,
participation in social activities, and quality of life for this population.

Public health relevance
Many aging Veterans require lower-limb amputations due to complications associated with vascular disease and diabetes. Lower-limb prosthesis users have reduced standing balance and balance confidence, which are associated with reductions in social activities and quality of life. Balance confidence does not improve over time with use of the prosthesis, suggesting that all efforts should be made to maximize balance and balance confidence during initial training with a prosthesis. The goal of this project is to develop a novel prosthetic foot- ankle system that can be adjusted by a physical therapist to gradually decrease stability as the patient learns to stand and walk with the prosthesis. Accordingly, patients will experience a gradual increase in the balance requirements of their prosthesis as their confidence and performance improves. We believe this gradual training approach will improve the balance and balance confidence of Veterans with lower-limb amputations, allowing them to engage in meaningful social activities and improving their quality of life.